Protein Transport Across Membrane by Bacterial Pathogens

Project Summary
This research seeks to understand the fundamental process of protein translocation across membrane
barriers in bacteria. To establish an infection or exchange antibiotic resistance genes, bacteria must transport
macromolecules including protein across multiple membrane barriers: their own and the host cell’s.
In response to the universal requirement for macromolecule export, bacteria have evolved elaborate
machineries called secretion systems that use energy to move macromolecules from the bacterial cell out into
the extracellular milieu or directly into a host cell. In this proposal, I focus on the Type IV secretion system
(T4SS). This family of secretion systems is unique in that there are T4SSs that can transport nucleic acid
and/or protein cargo. As an important example of a T4SS, I will first investigate the defect in organelle
trafficking / intracellular multiplication (Dot/Icm) T4SS in Legionella pneumophila. This system is essential for
pathogenesis, which can result in the potentially fatal pneumonia Legionnaires’ Disease. The Dot/Icm T4SS is
composed of 30 proteins in different copy numbers. It secretes over 300 protein substrates in order to evade
the host cell’s immune system and scavenge nutrients. This represents a much larger repertoire of substrates
than observed in other secretion systems that transport proteins out of the bacterial cell. Thus, the Dot/Icm
T4SS is an ideal model system for determining how these numerous substrates are engaged and transported.
Protein transport by T4SSs has traditionally been studied using cell-based assays. The cellular environment,
however, does not allow for precise control and manipulation of reaction conditions. The field needs rigorous
biophysical assays with which to dissect the molecular mechanism of protein translocation. I propose to
combine determination of high-resolution structures of the Dot/Icm T4SS by cryoEM and
thermodynamics and enzyme kinetics studies of the system. These approaches will complement
traditional genetic and cell biological strategies and will lead to mechanistic insights into how this secretion
system transports protein. For example, transient state kinetics experiments observing the ATP-dependent
translocation of a fluorescently labeled substrate protein will answer questions such as “which signal
sequences are recognized by which motor protein(s),” “are protein substrates unfolded during transport,” and
“which kinetic steps are coupled to ATP binding and hydrolysis?”
This approach to investigating complex cellular machinery by integrating biochemical, biophysical, structural,
and genetic approaches will shed new light on the fundamental process of translocation across multiple
membranes, an important feature of bacterial pathogenesis. While this work aims to understand the
fundamental mechanism of protein translocation, our findings could lay the foundation for scientists to develop
anti-virulence drugs, the next generation of tools fighting bacterial disease, and to engineer the targeted
delivery of gene and protein therapeutics to eukaryotic cells by secretion systems.

Public health relevance
Narrative / Public Health Relevance Integrated biophysical analyses of the Dot/Icm secretion system, an essential virulence factor for Legionella pneumophila, will provide the basis for the design of (1) anti-virulence drugs and (2) targeted delivery of gene and protein therapeutics. In order to exploit this bacterial system which evolved to deliver macromolecules to eukaryotic cells, we must understand how the Dot/Icm system selects and engages the cargo it transports across membrane barriers. The development of in vitro thermodynamics and kinetics assays to define the key steps in this process, testing mechanistic hypotheses derived from high-resolution cryoEM structures, will pave the way for new technologies to prevent infection and develop therapeutics.